Health care hotspotting: inside the Camden Coalition's superutilizer program

ABSTRACT
This project extends the analysis of a randomized controlled trial of the Camden Coalition of Healthcare
Providers’ complex care management program, an intervention that aims to reduce spending and improve
healthcare quality and health outcomes by targeting “superutilizers” of the healthcare system. The program
focuses on patients with chronic conditions, complex needs, and frequent hospitalizations, working with them
after discharge to prevent future admissions. The program is motivated by the fact that healthcare costs (which
account for almost 18 percent of GDP in the US) are heavily concentrated. It targets a group that accounts for
less than two percent of the Camden population but more than a quarter of total spending at Camden
hospitals.
Our previous randomized controlled trial found that the care coordination program failed to reduce hospital
readmissions, but it could not explain why. This follow-up research will address this unanswered question by
investigating new outcomes that distinguish between two very different explanations with very different
implications: a failure of trial fidelity to the program or of the underlying theory behind the program. Was
postdischarge care coordination (such as getting patients to primary care appointments in a timely manner) not
achieved or was it insufficient to prevent readmissions? This work is a rare opportunity to conduct a
postmortem on a critically important but limited RCT and chart a path forward for improving care for medically
and socially complex patients.
We leverage rich Medicaid data to investigate these alternative explanations for the lack of program impact on
hospital readmissions, expanding the scope of inquiry beyond hospital utilization to shed light on the program’s
impact on other important healthcare utilization and health behaviors, which are key elements of the program’s
theory of change. The specific aims are motivated by a need to better understand the null findings on hospital
readmissions, inform the current debate over their interpretation, and investigate potential impacts of the
intervention outside of the hospital setting. We will use the randomized controlled design to investigate the
impact of the Camden program on (1) Quantity of outpatient care, including primary care, specialist care,
prescription drugs, home care, and durable medical equipment; (2) Quality of outpatient care, as proxied by
measures of care fragmentation and whether care was received in a timely manner after discharge; and (3)
Patient health behaviors, including medication adherence and the stability of enrollment in Medicaid. We will
also conduct interviews with program staff to understand implementation challenges, contextualize findings,
and generate new hypotheses.

Public health relevance
PROJECT NARRATIVE Our previous work found no impact of a much-heralded care management program on hospital readmissions for individuals with high healthcare use and complex medical and social needs. By examining outpatient records not previously available, the current project expands this inquiry to examine why the program was unsuccessful at reducing readmissions: were care coordination goals not met or was improved care coordination unsuccessful in reducing readmissions? The study will shed light on whether better management of post-discharge care can reduce further utilization or whether a more complete redesign of systems serving complex patients is needed to improve patient outcomes.